Impact of Glucose Variability on Dynamic Cognitive Function in Youth with Type 1 Diabetes

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is one of the most common chronic childhood diseases and has a rapidly rising
incidence and prevalence. Management of blood glucose is challenging and often leads to frequent and rapid
swings between normal, high, and low glucose. This glucose variability has recently been identified as an
independent risk factor for diabetic complications. One of the least studied and understood complications of
T1D is altered cognition and its relationship to glucose variability. As the brain uses a substantial amount of the
body’s glucose to support its functions, especially during dynamic periods of brain development, there are
strong biological reasons for the potential vulnerability of youth with T1D. Several studies have shown lower
cognitive scores in youth with T1D compared to their peers without T1D, and shown that poorer overall
glycemic control as indicated by severe glycemic events (e.g., diabetic ketoacidosis) and chronic
hyperglycemia, are associated with lower cognitive scores both acutely and long-term. However, these studies
we conducted in a controlled, optimized laboratory settings at a single time point. Little is still known about how
typical glucose fluctuations that occur daily in real-life settings affect cognitive function in the moment,
particularly dynamic cognitive skills that are sensitive to environmental or physical conditions of the individual
(e.g. sleep deprivation) and thus fluctuate throughout the day (e.g., working memory, processing speed).
Determining the relationship between glycemic fluctuations and dynamic cognitive function is critically
important in youth given that dynamic cognitive skills are fundamental for learning, integrating, and
using novel information in their daily lives. Understanding how these skills are affected in daily life, how
they relate to glycemic fluctuations, and any contributing factors, could motivate improvements in academic
accommodations and T1D treatment recommendations. Importantly, this work could also be expanded to
better understand the impact of glycemic variability on brain health throughout the lifespan in T1D and could be
translated to other forms of diabetes (e.g., type 2 diabetes, gestational diabetes). The primary goal of this study
is to determine if real-time, real-life glycemic variability predicts fluctuations in dynamic cognitive function in
youth with T1D. A secondary goal is to determine whether dynamic cognitive function in youth with T1D differs
from youth without T1D, independent of significant glycemic extremes. To address these questions, I will apply
a unique and innovative combination of continuous health and cognitive data collection methods, multivariate
time-series analyses, and machine learning models. This work, combined with a tailored career development
plan, will form the basis of my future work as an independent investigator, which will expand to address how
diabetes-related health behaviors (e.g., food choice) impact glucose fluctuations, and subsequent brain health
(i.e., cognitive function), using novel mobile health (mHealth) technologies across different types of diabetes.

Public health relevance
PROJECT NARRATIVE One of the least studied and understood complications of type 1 diabetes (T1D) is altered cognition and its relationship to glucose variability; and although a few studies have shown lower cognitive scores associated with diabetes when measured in optimal laboratory settings, little remains known about how typical glucose fluctuations that occur daily in real-life settings affect in-the-moment cognitive function, particularly dynamic cognitive skills that also fluctuate throughout the day. The primary goal of this study is to determine if real-time, real-life glycemic variability predicts fluctuations in dynamic cognitive function in youth with T1D using a unique and innovative combination of continuous health and cognitive data collection methods, multivariate time- series analyses, and machine learning models. This work, combined with a tailored career development plan, will form the basis of my future work as an independent investigator, which will expand to address how diabetes-related health behaviors (e.g., food choice) impact glucose fluctuations, and subsequent brain health (i.e., cognitive function), using mobile health technologies across different types of diabetes (e.g., T1D and type 2 diabetes across the lifespan), with the ultimate goal of improving treatment recommendations and quality of life for these populations.